Epilepsy Multiplatform Variant Prediction (EpiMVP) - Admin Core

The overall mission of the Epilepsy Multiplatform Variant Prediction (EpiMVP) Administrative Core is to oversee
and coordinate the activities of the EpiMVP Center Without Walls (CWOW), including the work of the Gene and
Variant Curation Core (GVCC), the Human Epilepsy Tools Core (HETC), the three Scientific Projects, as well as
center-wide matters related to the program charter, publications, data sharing, communications with the scientific
and lay communities, and ethical/legal issues. The Administrative Core’s Principal Investigators (PIs)/Directors,
Drs. Lori Isom and Jack Parent, who have a successful track record of working together, coordinating groups of
investigators, conducting multiple projects simultaneously, and disseminating research findings, will provide
overall leadership to EpiMVP throughout the five years of the proposed Center. Drs. Isom and Parent will also
serve as Co-Chairs of the EpiMVP Steering Committee, which will be composed of all EpiMVP PIs and Core
Directors (Dr. Ross, Dr. Wang, Dr. Carvill, and Dr. Uhler) and have responsibility for the strategic direction and
operational activities of the entire Center. The EpiMVP Program, centered at the University of MI and reaching
out to the University of CA-San Francisco, Northwestern University, the University of WA, and Weill Cornell
Medicine, is composed of international experts in genetics, clinical care, computational biology, neuroscience,
pharmacology, and electrophysiology who are at the forefront of epilepsy research with broad expertise in the
study of gene variants linked to developmental and epileptic encephalopathies and other genetic epilepsies.
Long-term, on-going collaborations are in place between many investigators. The addition of three investigators
to the epilepsy field, Dr. Ross, Dr. Schnell, and Dr. Bai, strengthens the CWOW and brings a fresh perspective
to known problems in epilepsy research. Strong institutional support, provided to the group by the University of
MI Medical School and the University of MI Departments of Pharmacology and Neurology in the form of
administrative infrastructure, planning grant funding, and trainee support, further insures the success of this
proposal. The EpiMVP Administrative Core seeks to accomplish the following Milestones: 1. To provide
leadership and expertise for the planning, development, coordination, and overall administration of EpiMVP. 2.
To oversee reporting of CWOW activities within its membership and to NINDS and to disseminate information
regarding EpiMVP findings to a broad constituency, from scientists to clinicians to patients and families. 3. To
help train and mentor the next generation of scientists to advance the understanding and treatment of genetic
epilepsies. The expected outcomes of the EpiMVP Administrative Core are: 1) Leadership of an efficient,
productive, and collaborative multi-institutional CWOW; 2) Effective communication between EpiMVP members
and NINDS, as well as rapid dissemination of results to the research community, healthcare professionals, and
patients/families, 3) Training and mentoring of the next generation of epilepsy researchers.